Southwest Idaho Bridges to Baccalaureate Program

PROGRAM SUMMARY
The Southwest Idaho Bridges to the Baccalaureate (SWID B2B) program is an enduring undergraduate
research program in Idaho that supports both the transition of underrepresented (UR) students from the College
of Western Idaho (CWI) community college into biomedical degree programs at Boise State University (BSU)
and their successful graduation. The SWID B2B program was originally developed using a previous NIH R25
funding mechanism and will be entering its second five-year span under the T34 mechanism. Based on statistics
from our institutional self-assessments, the SWID B2B program has the long-term goal of increasing the number
of individuals from UR groups in Idaho that pursue research careers in the biomedical sciences. The short-term
goals of this T34-funded B2B program are to i) increase the number of UR CWI community college students that
transfer to BSU into biomedical science majors, ii) increase retention and graduation rates for UR biomedical
science transfer students, and iii) prepare UR students for careers in the biomedical sciences. In steady state,
this program will serve hundreds of students per year and include annual B2B cohorts of 10 UR students. To
accomplish our goals, we request funding for the following five specific aims. Aim 1. Recruit and select
program participants. The objective of this aim is to Recruit UR students with strong potential interests in
futures that include biomedical research and to Select UR students (in cohorts of 10 per year) into the B2B
program. Aim 2. Advise and prepare student trainees. The object of this aim is to Advise CWI students early
and continuously through program ambassadors and to Prepare students for a research experience by offering
B2B-enhanced courses at CWI and providing peer mentoring. Aim 3. Immerse and include student trainees.
The objective of this aim is to Immerse community college students in a biomedical research experience with a
faculty mentor during the summer before they transfer to the university campus and to Include students in the
everyday activities associated with biomedical research. Aim 4. Equip and support student trainees. The
objective of this aim is to Equip students as they move through their degree program at BSU by providing an
academic-year research experience and a professional development course, as well as to Support students for
success by providing them continued scientific mentorship and the opportunity to present their research data
nationally. Aim 5. Continually engage and launch program participants. The objective of this aim is to
Continually Engage students as they leave SWID B2B and move through their degree program at BSU by
encouraging all students to continue their research in their mentor’s lab, enroll in a senior level seminar course,
and when appropriate, apply for additional summer fellowships. Studies have demonstrated that undergraduate
research experiences like the B2B program have an important positive impact on UR groups, and we expect that
our SWID B2B program will have enduring effects, transform the lives of UR students, and improve their success
as they move forward into biomedical careers.

Public health relevance
PROJECT NARRATIVE The T34 Bridges to the Baccalaureate proposal is designed as a continuation of the Southwest Idaho Bridges to Baccalaureate (SWID B2B) Program, an enduring undergraduate research program in Idaho currently funded by the NIH R25 mechanism. The SWID B2B program supports both the transition of underrepresented (UR) students from College of Western Idaho community college into biomedical degree programs at Boise State University and their successful graduation. This B2B program has established the long-term goal of increasing the number of individuals from underrepresented groups in Idaho that pursue research careers in the biomedical sciences. The short-term goals of this B2B program are to i) increase the number of UR students who transfer to BSU into biomedical science majors, ii) increase retention and the number of UR students that graduate from BSU, and iii) prepare UR students for careers in the biomedical sciences. This program will include annual cohorts of 10 UR students and will also benefit many others through enhanced courses and information regarding the biomedical research career landscape.